REIT Investments in Nursing Homes and the Quality of End of Life Care for Residents with Alzheimer's Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease and related dementias (ADRD) affect 5.5 million people in the US and account for $305 billion in
health care spending annually. Nearly half of all Medicare decedents have an ADRD diagnosis prior to death. Nursing
homes play an important role in end-of-life (EOL) care for individuals with ADRD. Among the 1.4 million nursing home
residents in the US, 68% have some degree of ADRD, with the prevalence expected to increase. More than two-thirds of all
ADRD-related deaths occur in nursing homes. Nursing home ownership has been associated with the quality of EOL care
for residents with ADRD. Among US nursing homes, 12% have investment from real estate investment trusts (REITs). It
is not known whether REIT investments in nursing homes are associated with the quality of EOL care. The prevalence and
increasing rates of these corporate investments have raised concerns among policymakers and oversight agencies including
the Government Accountability Office, MedPAC, the House Ways and Means Committee, the Senate Finance Committee,
and The White House. The Centers for Medicare and Medicaid Services have proposed a new rule that would require public
reporting of REIT investments in nursing homes. REITs are for-profit public or private corporations that invest in income-
producing properties. They are “pass-through entities” which qualify for tax exemptions if they satisfy requirements related
to sources of income and assets, including disbursing 90% of their taxable income to shareholders as dividends. These
corporations purchase a nursing home's property and lease it back to the nursing home operator. Under this arrangement,
the operator pays all of the expenses of the property, including real estate taxes, building insurance, and maintenance. These
expenses are in addition to the cost of rent and utilities that are paid to the REIT by the operator. REITs are not directly
involved in nursing home operations, though they may provide guidance to help the operator achieve profitability goals.
Selling a nursing home's property to a REIT provides the operator with an infusion of capital that can conceivably be used
for facility improvements and/or to provide more resources for resident care. However, annual rent escalations that are
typically included in the leases may make rent unaffordable for nursing home operators over time and potentially lead to
reductions in staffing, supplies, or equipment that negatively impact the quality of EOL care. Preliminary analyses indicate
that registered nurse staffing levels in nursing homes are often reduced following REIT investment. For this project, a
nationally representative database of nursing home residents with ADRD will be constructed from Medicare claims and
Minimum Data Set assessments and merged with a novel database of REIT investments in nursing homes for the period
2012-2022. This will be the first study of the relationships between REIT investments in nursing homes and the quality and
cost of care at the EOL for residents with ADRD. The project addresses priority areas of the National Institute of Aging by
identifying economic and organizational factors associated with the use and quality of health care services for individuals
with ADRD. The results will provide important insights sought by policymakers that will also benefit payers and nursing
home residents with ADRD and their families.

Public health relevance
PROJECT NARRATIVE Over two-thirds of all deaths associated with Alzheimer's disease and related dementias (ADRD) occur in nursing homes with the quality of end-of-life care varying by type of ownership. Twelve percent of US nursing homes have received investments from real estate investment trusts (REITs) with the impact on end-of-life care being unknown. Using a novel database of REIT investments in nursing homes, this is the first study of the relationships between these investments and the quality and cost of care at the end-of-life for residents with ADRD.